Investigating the Role of Extracellular Matrix in Down Syndrome Associated Cardiac Phenotypes.

PROJECT SUMMARY
Congenital heart defects (CHD) affect ~1% of all births and are the leading cause of morbidity and mortality in
infants. Notably, over 50% of Down Syndrome (DS) infants, the most prevalent autosomal abnormality caused
by trisomy 21 (T21), are born with a CHD, with septal defects most common. The pathways that contribute to
cardiac defects in T21 are poorly understood. The critical region of human chromosome 21 associated with CHD
harbors genes coding for extracellular matrix (ECM) as well as cell-ECM and cell-cell adhesion proteins, among
others. Using T21 hiPSCs derived from DS individuals, our preliminary data show increased ECM, tissue
stiffening, and altered ECM-cell interactions in iPSC derived cardiomyocytes compared to isogenic controls. We
also observe precocious differentiation including changes in cell cycle, contractility, and nuclear morphology.
Based on compelling preliminary data, we hypothesize that disruption of ECM during heart development
leads to downstream effects on cell signaling and to cytoskeletal reorganization that impacts nuclear
architecture and gene expression programs. We will test this hypothesis using 3D cardiac models, providing
a unique opportunity to investigate critical pathways at the molecular, cellular, and tissue level. In Aim 1 we test
the idea that a maladaptive ECM-integrin circuit impacts costamere formation and downstream signaling in
cardiac models. In Aim 2 we will test the idea that ECM alterations can impact nucelar architecture and genome
organization through cytoskeltal reorganization. Understanding mechanobiological regulation of heart
development in T21 will fill a major knowledge gap and is expected to reveal new molecular mechanisms that
contribute to CHD. More broadly, this work has the potential to identify therapeutic modalities that minimize DS-
associated phenotypes as well as provide a broader solution to a range of diseases involving ECM alterations
including age-related degeneration, fibrosis, and cancer.
The fellowship training plan capitalizes on the well-established expertise of the Boyer lab in cardiac gene
regulatory mechanisms and Dr. Boyer’s extensive mentorship experience, as well as the input of leading experts
in the fields of nuclear architecture, cell adhesion and ECM. Dr. Boyer’s lab at the Massachusetts Institute of
Technology in both the Biology and Biological Engineering Departments is an ideal research and training
environment, facilitating ample opportunities for collaboration and the ability to pursue creative and challenging
projects. This project will allow me to develop new skills and expertise that will provide the strongest foundation
for my development as an independent researcher.

Public health relevance
PROJECT NARRATIVE Over 50% of Down Syndrome (DS) infants are born with a congenital heart defect, with septal defects most common. We propose to systematically investigate how increased extracellular matrix (ECM) impacts downstream cellular pathways using cardiac models derived from human Trisomy 21 iPSCs. We expect our study will open new avenues for therapies that minimize DS phenotypes as well as more broadly for other ECM related diseases including age-related degeneration, fibrosis, and cancer.